Developing DWORF gene therapy to treat heart failure and muscular dystrophy

PROJECT SUMMARY
Calcium is an essential regulator of muscle function and its dysregulation contributes significantly to the common
pathogenic signaling cascades that drive multiple striated muscle diseases including heart failure and muscular
dystrophy. The sarcoplasmic reticulum (SR) is the major calcium storage site in muscle and SR calcium loading
is achieved by the SR calcium-ATPase (SERCA). Cardiomyocytes from human heart failure patients show robust
calcium defects including decreased systolic calcium transients, increased diastolic calcium, and SR calcium
leak, which contributes to impaired contraction/relaxation and can induce arrhythmias. Muscular dystrophy is a
family of genetic disorders caused by mutations in genes that serve a structural role in stabilizing the membrane
of skeletal muscle myofibers and cardiomyocytes. These mutations result in membrane instability, rupture, and
unregulated calcium influx leading to mitochondrial calcium overload and myocyte necrosis. Numerous studies
have shown that in heart failure and muscular dystrophy, calcium homeostasis can be restored by enhancing
SERCA activity or expression, thereby reducing cytosolic calcium and increasing SR calcium stores, resulting in
significant protection from disease. We recently discovered a novel SR membrane microprotein, DWORF, that
binds to SERCA and potently activates its calcium transport activity. In mice, DWORF overexpression in the
heart leads to robust SERCA activation, increased SR calcium uptake and SR calcium stores, faster cytosolic
calcium clearance, and increased cardiomyocyte contractility. Additionally, DWORF overexpression by cardiac-
specific transgene or adeno-associated virus (AAV9)-mediated gene delivery has proven to be cardioprotective
in experimental and genetic mouse models of heart failure. Notably, a significant limitation to previous AAV9-
DWORF gene therapy studies in mice has been the reliance on gene delivery in neonates to achieve meaningful
cardiomyocyte infectivity, as adult cardiac and skeletal muscle are not efficiently targeted by AAV9. A recent
breakthrough in the field was achieved with the development of the muscle-tropic MyoAAV capsid, which is
significantly more potent than any current AAV in transducing cardiac and skeletal muscle. Here we will leverage
the optimized MyoAAV system to comprehensively assess the therapeutic potential of DWORF gene therapy in
mouse models of striated muscle disease with diverse etiologies where calcium dysregulation plays a primary
role in disease pathogenesis. Aim 1 will use two distinct mouse models of heart failure, myocardial infarction and
pressure overload, which mimic different clinically relevant scenarios. Aim 2 will employ a robust model of
muscular dystrophy caused by combined loss of dystrophin and utrophin, and analysis will focus on both cardiac
and skeletal muscle. Aim 3 will utilize a newly developed humanized mouse model of monogenic phospholamban
disease, which presents with calcium defects that lead to ventricular arrhythmias. In all 3 Aims, we expect that
MyoAAV-DWORF gene therapy will protect from cardiac and skeletal muscle disease pathogenesis and these
findings will inform on future translational studies in large animals and human gene therapy trials.

Public health relevance
PROJECT NARRATIVE Heart failure and muscular dystrophy are devastating diseases that affect tens of millions of people worldwide, and while these disorders are highly complex in nature, a common feature they share is dysregulated calcium signaling. We recently discovered a small protein called DWORF that can rescue calcium defects in the heart when it is overexpressed and protects from disease. The studies proposed here will leverage a newly developed gene therapy strategy that is optimized for enhanced heart and skeletal muscle gene delivery to comprehensively test the therapeutic potential of DWORF as a novel gene therapy target for the treatment of heart failure and muscular dystrophy.